Genome instability induced by homologous recombination

Project Summary
The general goal of the proposed research is to define the pathways and their mechanisms by which
homologous recombination contributes to genome instability in somatic cells through events involving repeated
DNA sequences. Using the budding yeast Saccharomyces cerevisiae as a model organism we will define the
mutational signatures of multi-invasion-induced rearrangements, which are induced by a single Rad51-ssDNA
filament simultaneously pairing with repeated DNA sequences on different chromosomes or locations on a
single chromosome. The aims are designed to establish novel mechanisms and paradigms that are applicable
to central questions concerning genomic stability and genome maintenance. We will establish novel mutational
signatures caused by homologous recombination that will help to define the mechanism underlying such
signatures found in humans, including cancer genomes. Moreover, our work will contribute to understanding
the mechanisms underlying major processes that shape genomes during ontogenic development and
evolution, including non-allelic homologous recombination, insertions, mutation showers (kataegis), double
minute chromosome formation, and chromosome instability syndromes such as chromothripsis. The Specific
Aims are: (1) Determine the genetic consequences of multi-invasion-induced genome rearrangements. and (2)
Identify pathways that affect multi-invasions and the genome-wide search for homology. Both aims require the
use of the table-top centrifuge requested in this application.

Public health relevance
Project Narrative Homologous recombination is a pivotal tumor suppressor pathway by maintaining genomic stability and is critical in repairing DNA lesions that are induced by ionizing radiation and other common modalities of DNA damaged-based anti-cancer therapy. Homologous recombination also reshapes genomes during meiosis, evolution, and ontogenic development affecting fertility, speciation, and human disease, especially cancer. The proposed project will lead to an improved mechanistic understanding of this critical DNA repair pathway and its contributions to remodel genomes.